Connecting Latinos en Pareja: A Couples-based HIV Prevention Intervention for Latino Male Couples

Project Summary
Despite recent emphasis on couples-based HIV prevention interventions, efficacious interventions for Latinx
male couples have yet to be tested. The proposed study is a randomized controlled trial (RCT) of an HIV
prevention couples-based intervention - Connecting Latinxs en Pareja (CLP). CLP is based on our team’s
extensive formative work with couples, including remote delivery of study protocols and the use of biomarkers
of adherence to HIV treatment and pre-exposure prophylaxis. CLP was specifically tailored to the needs of
Latinx male couples. CLP, a four-session intervention grounded in social cognitive theory and a relationship-
oriented ecological framework, has demonstrated high feasibility and acceptability in a recent pilot RCT and
promising evidence of changes in key intervention mechanisms and outcomes. CLP is novel in that it (1)
integrates both biomedical prevention techniques (i.e., pre-exposure prophylaxis [PrEP] and treatment as
prevention [TasP]) and psycho-educational skill building; (2) offers culturally competent and linguistically
appropriate information and education about options for PrEP and ART; (3) is driven by an HIV status-neutral
prevention and treatment approach designed to address HIV prevention and care needs among
seroconcordant (positive and negative) and serodiscordant couples; (4) employs an innovative algorithm for
measuring HIV protection that goes beyond condom use as the sole indicator of HIV protection; and (5) is
culturally tailored to Latinx couples to address social, environmental, and contextual factors that intensify HIV
risk in this population including HIV-related stigma and discrimination. We will examine whether participants
assigned to CLP report an increase in the proportion of HIV protected anal sex acts to those assigned to a
Wellness Promotion (WP) time and attention matched control condition. The primary outcome, HIV protection,
is operationalized with a validated composite algorithm as protected acts of anal intercourse (i.e., anal sex acts
in which condoms, pre-exposure prophylaxis (PrEP), treatment as prevention (TasP), or a combination thereof,
are used to reduce risk of HIV transmission) within the couple and with outside partners. We will recruit 150
Latinx male couples (N=300 individuals) from 50 Ending the HIV Epidemic (EHE) jurisdictions and an
additional 17 jurisdictions with high HIV burden among Latinos. Follow-up will occur every 3 months over 9
months, and biological (self-testing for HIV and hair biomarkers for PrEP and ART adherence) and behavioral
and psychosocial data will be collected. We will derive practical recommendations and considerations for key
stakeholders to expand and improve implementation of CLP or other next steps as indicated by study results.
To our knowledge, this study will be the first to examine the efficacy of a couple-based intervention to increase
HIV protection for Latinx male couples capable of being scaled up to provide continuous support and protection
for this heavily impacted group.

Public health relevance
Project Narrative The proposed study is highly significant because it targets a disproportionately affected group, Latinx men who have sex with men, and tests a culturally adapted, flexible intervention, Connecting Latinos en Parejas, developed specifically for Latinx male couples. The project is innovative in that it includes Latinx couples regardless of HIV status and expands prevention alternatives offered in other couples-based interventions by incorporating biomedical prevention methods such as pre-exposure prophylaxis (PrEP), promoting engagement in care, adherence to treatment regimens and viral suppression (TasP) and encouraging routine HIV testing if appropriate given the couple’s serostatus. Our intervention targets multiple points in the HIV Prevention and Care Continuum and is responsive to the Ending the HIV Epidemic Initiative and National HIV/AIDS Strategy (2022-2025).